Evaluating human T cells specific for Mycobacterium tuberculosis antigens that are processed and presented by infected macrophages

We have only a basic understanding of how variation in human T cell responses elicited after Mycobacterium
tuberculosis (Mtb) exposure and infection are linked to clinical outcomes. Emerging data in animal models and
humans demonstrate that direct T cell recognition of Mtb-infected macrophages, the niche cell for Mtb infection,
is central to a protective response. The premise of this proposal is that insight into which antigens are processed
and presented by Mtb-infected macrophages, together with the composition, distribution, and kinetics of the T
cell repertoire that target these antigens is vital to developing vaccines that prevent active tuberculosis (TB). In
Uganda, our original study of household contacts (HHCs) of active pulmonary TB cases (since ’02) not only
captured co-prevalent and incident TB but also new Mtb infection characterized by IFNg release assay (IGRA).
Our current, follow-up TB HHC study focused on enrolling asymptomatic IGRA-negative contacts to identify
persons undergoing IGRA conversion, i.e. “converters” (CVTR). HHCs with baseline and stable positive IGRAs
in follow-up (i.e. LTBI), and “nonconverters” (NCVTRs), who remained IGRA negative, were also enrolled.
Evaluating T cells and MF from peripheral blood and broncho-alveolar lavage (BAL) samples from the CVTRs
form the basis of our proposed studies focusing on longitudinal immune responses.
The experimental approach for this proposal builds on two complementary, ongoing lines of investigation.
First, to quantify Mtb-derived peptide presentation in the context of diverse HLA alleles in Mtb-infected cells, we
developed mass spectrometry approaches. Despite MHC-II allelic diversity, we found that peptides derived from
CFP10, an Esx1 protein which is absent in the BCG vaccine, were presented by all MHC-II alleles analyzed
while other antigens were found only in the context of certain MHC-II alleles. Second, using single-cell RNA
sequencing (scRNAseq) with T antigen cell receptor (TCR) mapping, we found that Mtb-specific CD4+ T cell
recognition of infected macrophages is variable and depends both on macrophage phenotype and T cell antigen
specificity. Leveraging our team’s combined expertise, we will define the antigens presented by Mtb-infected
macrophages and compare Mtb-specific T cell responses to these antigens at early vs. late time points after
IGRA conversion, in peripheral blood and in the lungs. In Aim 1, we will use immunopeptidomics to identify Mtb
antigens presented on Mtb-infected human macrophages. We will then enumerate the circulating CD4+ T cells
specific for these antigens after Mtb exposure and IGRA conversion among CVTRs. In Aim 2, we will quantify
direct T cell recognition of Mtb-infected macrophages, using scRNAseq to determine the TCR repertoire, antigen
specificity, and function of T cells from BAL and peripheral blood, longitudinally, after IGRA conversion. In Aim
3 we will compare the capacities to control bacterial growth among human CD4+ T cells that target antigens
presented by Mtb-infected monocyte-derived and alveolar macrophages vs. other immunodominant Mtb
antigens. The antigens, TCRs, and T cell functions gained from this project will directly inform TB vaccine design.

Public health relevance
PROJECT NARRATIVE Among human T cells specific for Mycobacterium tuberculosis (Mtb) antigens, little is known about the magnitude and kinetics of the subset able to directly recognize infected macrophages, the cellular niche for Mtb. Using pulmonary and peripheral blood T cells from a longitudinal cohort of household contacts with recent Mtb exposure and IGRA conversion, we track CD4+ T cell clonotypes specific for Mtb antigens identified as presented by Mtb- infected macrophages. This research project contributes to TB vaccine development by determining the antigens targeted by T cells that recognize infected macrophages and examines the dynamics of Mtb-specific T cell responses at early and late time points after natural Mtb exposure and infection.